Molecular Biophysics Training Program

Program Summary / Abstract
The Molecular Biophysics Training Program (MBTP) at the University of Washington
(UW) is designed to train predoctoral students to apply state-of-art physical and quantitative
approaches to the investigation of biomedically relevant systems at molecular and cellular
levels. In the post-genomic era, basic and translational research in many biomedical areas
will benefit from a wider application of rigorous and quantitative biophysical methods, which
requires a highly trained workforce proficient in conducting research with these methods. The
overarching objective of MBTP is to meet these needs by enhancing the research experience
and training of selected UW predoctoral students interested in molecular biophysics and
preparing them to develop a productive career in health-related research in academia,
government, and the private sector.
MBTP trainees are chosen each year through a rigorous selection process that
identifies the top graduate students from a large pool of talented and diverse applicants
admitted to UW through four interdisciplinary programs and nine departmental programs.
During their graduate career, MBTP trainees are provided with structured activities to expose
them to a wide range of biophysical methods, techniques, and research topics that go beyond
their home graduate program. These include, but are not limited to, a bi-weekly student
research presentation series, a peer-organized student journal club and discussion group, an
annual retreat that involves the trainees, their advisors, and a larger local biophysics
community, as well as other lectures and courses required or supported by this program and
related UW departments.
This Training Program plays a special role in UW by actively nucleating a cross-
departmental biophysics community. It fosters close interactions among trainees and their peer
pre-doctoral students, who share common interests in molecular biophysics, but are otherwise
separated by departments and graduate programs. By taking advantage of a growing body of
UW faculty with biophysics background, MBTP creates a unique platform, where trainees can
learn about modern biophysical techniques, gain knowledge of emerging challenges in
biomedical research, and build and extend their professional network. The training program has
a strong record of success and impact as evidenced by the productivity of its trainees during
and after graduate school and by the diverse career choices they make after they leave
graduate school.

Public health relevance
Project Narrative The Molecular Biophysics Training Program is designed to train the top graduate students at the University of Washington in modern biophysics, the development and application of state-of-the-art physical and quantitative approaches to systems of biomedical importance. The training program plays a special role in the local biomedical research community by bringing together highly talented graduate students from a wide variety of disciplines, such as Biochemistry, Chemistry, Pharmacology, Microbiology, Physics, Computer Sciences, and Engineering. This interdisciplinary training experience affords future leaders of academia and industry to broaden their scientific horizons well beyond what they would normally learn in graduate school and prepare them to undertake rigorous and quantitative research, which is essential for making new discoveries in both basic sciences and biomedical applications.